Arterial stiffness, brain morphology, cognition, and dementia in U.S. Hispanics/Latinos

Cognitive impairment and Alzheimer's disease and related dementias (ADRD) are pressing public health
concerns as the population ages. In the U.S., Hispanics/Latinos have a higher MCI and ADRD risk compared
with other population groups, and they are expected to contribute disproportionately to the expected increase
in mild cognitive impairment (MCI) and ADRD. Factors explaining this disparity are unknown. Higher central
arterial stiffness is posited to alter microvasculature structure and function in the brain contributing to cerebral
small vessel disease and with cognitive impairment and risk of ADRD in older white and black adults. No
reports to date have examined these associations in a large, diverse Hispanic/Latino population. Similarly, the
important roles of sex, obesity, the metabolic syndrome, and type 2 diabetes in these associations have not
been assessed. U.S. Hispanics/Latinos have a high burden of cardiometabolic risk factors that are associated
with both greater arterial stiffness and risk of ADRD and could contribute to the health disparity in MCI and
ADRD. We propose to address these gaps in an ancillary study to the 2019-2022 Visit 3 examination of ~9,297
participants in the Hispanic Community Health Study/Study of Latinos (HCHS/SOL), an ongoing cohort study
of well-characterized U.S. Hispanic/Latinos. We propose to add pulse wave velocity, a non-invasive arterial
stiffness measurement, to participants ≥45 years old during Visit 3 (n ~7,020). All other data will be available
from HCHS/SOL and its two ancillary studies. The Study of Latinos-Investigation of Neurocognitive Aging
(SOL-INCA) will provide data on cognitive performance and MCI and dementia classification for cohort
members ≥45 years old at Visit 3 (~6,272). INCA-MRI will provide brain magnetic resonance imaging (MRI)
data on a sample of cohort members (2017-2019, n ~2,800).
The study aims are the following: Aim 1. Estimate the association of central arterial stiffness and cerebral
small vessel disease (cerebral white matter hyperintensities, white matter integrity, and infarcts) overall and by
sex. Aim 2. Estimate the association of central arterial stiffness and domain-specific cognitive function overall
and by sex in participants ≥45 years old. Aim 3. Estimate the association of central arterial stiffness and MCI
and ADRD overall and by sex in participants ≥45 years old. For all aims, we will evaluate obesity, the metabolic
syndrome, and type 2 diabetes as potential modifiers.
This cost-efficient ancillary study will, for the first time, contribute novel information on the association of central
arterial stiffness and brain structure and function in a large sample of Hispanic/Latinos, a population burdened
with a high levels of metabolic impairments. Additionally, the inclusion of middle-aged adults will provide
insights into opportunities for early intervention prior to onset of overt disease. Understanding how arterial
stiffness influences cognitive impairment and ADRD will contribute novel information on identifying potential
targets for intervention, reducing health disparities, and the promoting cognitive resilience.

Public health relevance
This study examines the relationship of stiffening of the arteries and damage to small vessels in the brain, reduced cognitive function, mild cognitive impairment, and Alzheimer's disease-associated dementias. We propose to add a measure of stiffness of the arteries to the 2019-2022 re-examination of an existing, NHLBI sponsored cohort, the Hispanic Community Health Study/Study of Latinos; information on risk factors, damage to small vessels in the brain, cognitive function, mild cognitive impairment, and Alzheimer's associated dementias will come from the existing study and its sub studies. This study will provide new information on how stiffening of the arteries relates to brain structure and function in Hispanics/Latinos that can inform public health efforts to reduce health disparities and to identify potential targets to lower the risk of cognitive impairment and Alzheimer's disease associated dementias.